Functional state of CD8+ T cell immunity in adult T-cell leukemia/lymphoma

Title: Functional state of CD8+ T cell immunity in adult T-cell leukemia/lymphoma
Abstract
Adult T-cell leukemia/lymphoma (ATLL) is a fatal disease of malignant CD4+ T cells that develops in human T-
lymphotropic virus-1 (HTLV-1) carriers. Recent studies from our group and others further suggest that ATLL
diagnosed in the Caribbean region and North America (NA-ATLL) differ from those diagnosed in Japan (J-ATLL)
in both clinical presentation and immuno-genetic landscape. More than half of NA-ATLL patients in the U.S. are
immigrants of Caribbean descents. Relative to J-ATLL, NA-ATLL cases are diagnosed at a younger age but
present a more aggressive disease and face a shorter overall survival. Thus, improved understanding of
pathogenesis and novel therapeutic strategies are urgently needed.
It is well-known that anti-HTLV-1 immune surveillance plays a key role in preventing ATLL development. Multiple
lines of evidence support the notion that ATLL cells achieve immune escape not only by preventing antigen
presentation but also by suppressing systemic immune responses in the hosts. Hence, conceptually, therapies
that aim to augment anti-ATLL cytotoxic T cell response (CTL) should have therapeutic benefit. Currently, ATLL
is often managed with first-line chemotherapy which rarely achieves durable response in NA-ATLL and possibly
further damages already weakened CTL activity in the hosts. At the same time, multiple targeted therapies only
produced limited clinical efficacy. Most remarkably, two immune-modulating treatments, i.e. the anti-CCR4 mAb
mogalizumab and anti-PD-1 mAb Nivolumab, have failed in NA-ATLLs while showing some clinical benefits
among Japanese patients, highlighting the need to obtain an in-depth understanding of the host immune function
in NA-ATLL.
We recently developed a high dimensional spectral flow cytometry panel to achieve in-depth characterization of
both transformed and non-transformed T, B, and NK cells in PBMC samples from our Montefiore-Einstein ATLL
Biobank. We revealed that ATLL cells exhibited a phenotype associated with robust immunosuppression. We
also discovered in these patients a unique population of phenotypically exhausted CD8+ T cells, the proportion
of which decreased in a remission patient. In this proposal, we will test the hypothesis that ATLL cells induce a
general state of immunosuppression in patients that prevents an effective and durable anti-ATLL effector CD8+
T cell response. Using patient samples from our unique ATLL Biobank and those collected from the
Belinostat/Zidovudine/IFN trial conducted by Dr. Ramos (University of Miami), we will define new immune
correlates of favorable outcomes in this devastating blood cancer though high dimensional flow cytometry,
functional T cell assays, as well as single cell transcriptomic and T cell receptor clonotypic analyses.

Public health relevance
PROJECT NARRATIVE Human T-cell lymphotropic virus type 1 (HTLV-1) induced adult T-cell leukemia/lymphoma (ATLL) is a rare and fatal malignancy with limited therapeutic option. Our preliminary studies revealed that ATLL cells demonstrate a robust immune-suppression phenotype and there is a unique population of markedly expanded, phenotypically exhausted CD8+ T cells at the time of diagnosis. The objective of this study is to functionally characterize the suppressive activity of ATLL cells and define new immune correlates of favorable treatment outcomes in the context of the Belinostat/Zidovudine/IFN trial (NCT02737046).